National Biomedical NMR Resource at Madison

? DESCRIPTION (provided by applicant): The National Magnetic Resonance Facility at Madison (NMRFAM) is a resource center for biomolecular nuclear magnetic resonance (NMR) spectroscopy and small angle X-ray scattering (SAXS). NMRFAM aims to expand the frontiers of biomolecular NMR spectroscopy through resource technology and development programs in the important areas of (1) high-throughput determination of structures and functions of smaller proteins and RNA molecules, (2) technology for investigating the structure and dynamics of challenging systems, such as complexes, membrane proteins, paramagnetic proteins, and larger RNA molecules, and (3) efficient approaches to metabolomics, screening of small molecules binding to biological macromolecules, and natural product analysis. NMRFAM strives to be a model to the larger biological community for demonstrating cutting-edge capabilities of NMR spectroscopy. With the goal of broadening the scope of its scientific activities, NMRFAM hosts distinguished visiting scientists working in areas related to its research technology development projects. Through its collaborative activities, NMRFAM develops and disseminates advanced approaches that cover all steps in biomolecular NMR investigations. The center offers start-to-finish support for biomedical NMR investigations with assistance in one or more of the following steps: (1) strategy evaluation and experiment design, (2) preparation and labeling of proteins and nucleic acids, (3) feasibility studies, (4) data collection, (5) data analysis and structure determination, (6) data deposition, and (7) manuscript preparation. NMRFAM aims to facilitate the efficient pursuit of new knowledge by providing researchers with resources matched to their particular needs. A major goal is to develop methods for making these investigations faster and less costly as well as applicable to larger classes of proteins and nucleic acids of importance in human health. NMRFAM provides young investigators and experien

Public health relevance
PROJECT NARRATIVE Biomolecular nuclear magnetic resonance spectroscopy is the single approach that offers the most detailed information about biomolecules in solution, the milieu in which they normally function. NMR enables the discovery of three-dimensional structure, molecular dynamics, and molecular interactions--factors that reveal how biological systems work, are impacted by genetic and environmental factors, and respond to drugs.